Biostatistics and Data Science Core

Project Summary/Abstract – Biostatistics and Data Science Core (BDSC)
The Biostatistics and Data Science Core (BDSC) will provide statistical and data science support for all
projects within the Core and all SPORE investigators. The Core is comprised of biostatisticians with expertise
in lung cancer, clinical trials, higher dimensional data processing and analysis, and population studies.
Statistical and data science leadership ensures that SPORE study design and data analysis yield valid and
unequivocal answers to hypotheses being tested in projects. BDSC faculty and staff will provide statistical
leadership to all SPORE projects, linking study design, data collection and analysis to scientific goals of the
SPORE program. The BDSC will play an integral role in the collection, quality control, and analysis of data for
SPORE projects, as well as provide input on career enhancement and developmental research projects (CEP
and DRP), including support for study/experimental design, analysis, and reporting/publication. It is our
experience that statistical leadership in research that begins at the concept phase yields studies that are better
designed, more likely to answer the scientific questions of interest, and more compelling in their conclusions.
Our scientific projects will require and utilize a variety of assays, including high-throughput and multi-
parametric technologies, along with cutting-edge computational tools and modeling strategies that can be used
to analyze and integrate heterogeneous datasets and/or predict outcomes. Consequently, large-data
management and computational analysis will be an integral part of this research program. The efficient design
of clinical trials is also an important component in taking any intervention from bench to bedside. The BDSC
will serve as the quantitative piece of this collaboration by providing experimental and clinical trial design as
well as analysis and interpretation of data from all experiments and clinical trials that are conducted in the
SPORE. The Core will be organized around the three aims outlined below, and will directly leverage
infrastructures and resources already available at the Fred Hutch.